Elucidating mechanisms of fibrosis associated with the Crohns disease-associated pathogenic variant in the metal transporter ZIP8

PROJECT ABSTRACT
Inflammatory bowel diseases (IBD), including Crohn’s disease (CD) and ulcerative colitis, affect 1 in 200
Americans. Anti-tumor necrosis factor (TNF)-alpha therapies remain the cornerstone of therapy for patients
with IBD, but approximately 40% of patients will experience primary or secondary loss of response, and “anti-
TNF-experienced” patients are less likely to respond to all subsequent therapies in current clinical practice.
Single-cell RNA sequencing has uncovered key cellular signatures associated with anti-TNF refractoriness that
strongly implicate signaling between inflammatory macrophages and activated fibroblasts. There remains a
major gap in our understanding of the patient-specific factors that predispose to this aberrant macrophage-
fibroblast activation, how it links to anti-TNF unresponsiveness, and the potential to modulate it to change to
disease course and treatment response. Our work has focused on the functional implications of a pathogenic
variant in a metal transporter, ZIP8 A391T, that dysregulates manganese homeostasis and is associated with
complicated (stricturing and penetrating) Crohn’s disease. In studying ZIP8 391-Thr in a mouse model (Zip8
393T-knock-in (KI)), we have shown increased susceptibility to colitis, but even more interestingly, we have
observed enhanced fibrosis. These mice also exhibit marked induction of Il-11, a pro-inflammatory and pro-
fibrotic cytokine that is a hallmark of aberrant signaling between inflammatory macrophages and activated
fibroblasts in patients with Crohn’s disease – particularly anti-TNF refractory disease. We therefore
hypothesize that study of aberrant macrophage-fibroblast signaling is a key feature of disease pathogenesis in
the Zip8 393T-KI mice. Establishing the underlying disease mechanisms are important because (1) up to 25%
of patients with Crohn’s disease carry ZIP8 391-Thr in some populations and (2) the Zip8 393T-KI could serve
as a novel translational model for mechanistic studies, particularly related to anti-TNF non-response. We will
study this hypothesis in two aims: In Aim 1, we will determine if Zip8 393T-KI perturbs macrophage innate
immune responses; in Aim 2, we will compare fibroblast activation induced by Zip8 393T-KI vs. WT Zip8
macrophages. The long-term goal is to establish if ZIP8 391-Thr genotype has clinical implications for the
prevention of and treatment of patients with Crohn’s disease and use study of ZIP8 391-Thr-related pathology
as key opportunity to elucidate the role of Mn homeostasis in human disease. This R03 application builds from
a K08 that established the altered Mn homeostasis and fibroinflammatory phenotype in colitis in Zip8 393T-KI
mice. This application with strong translational relevance will provide critical mechanistic insight of the ZIP8
genotypic effect on macrophage-fibroblast signaling and the interaction with Mn homeostasis to prioritize
therapeutic targets, including STAT3 or IL-11 inhibition, and patient studies as part of an R01 application.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel diseases affect 1 in 200 Americans. Human studies have elucidated that signaling between key immune cells and stromal cells drive disease pathogenesis and determine response to therapy. This project will utilize an important pre-clinical genetic mouse model with direct relevance to at least 10% of patients with IBD to study these signaling pathways and interactions with micronutrient (zinc and manganese) availability.